Exploring the Use of a Web-Based Program for Older Adults Receiving Oral Anticancer Agents to Improve Communication and Self-Management

Oral anticancer agents (OAAs) are increasingly being prescribed and now account for over half of the new
cancer treatments approved by the Food and Drug Administration. Older adults have the highest incidence of
most solid tumor cancers and are often prescribed OAAs. Despite the speculated convenience of OAAs,
patients and their caregivers have steep literacy needs specific to information regarding this complex treatment
and are often met with numerous challenges. They must demonstrate self-efficacy in the management of
complex OAA regimens, adherence, symptom/side effect management, monitoring and reporting of drug
toxicities, potential drug-drug or food-drug interactions, and polypharmacy in the home environment.
Both patients and caregivers report that OAA information is inadequate, potentially affecting safe treatment
administration and management. Today, oncology care is shifting from oncology clinics to home environments,
resulting in implications for how care is delivered and communicated to patients, given the decreased
frequency of face-to face contact with oncology providers. Older adults have reported worse communication
with oncology providers related to chemotherapy treatment compared with their younger counterparts, leaving
older adults vulnerable to worse outcomes. Web-based programs offer a potential solution to increase
communication and generate new ways to support self-management of cancer care.
The specific aims of this mixed methods study are to: 1a) Explore concordance of the timing, frequency, and
continuity of information sharing and communication regarding OAA treatment between patients, caregivers,
and oncology health care providers 1b) Identify patient and caregiver OOA knowledge gaps; 2) Evaluate
patient-reported outcomes associated with the self-management of OOA treatment including health literacy,
satisfaction with OAA information, symptoms, self-efficacy for managing medication, social support for taking
medications, medications taken for other comorbid conditions, palliative care referral,and technology
ownership/use via quantitative questionnaires; ad 3) Assess web-based program design features that will
assist in the development of a future intervention tool to manage OAA treatment and to evaluate customized
considerations needed for older adult oncology patients using technology.
Findings will inform future research with aims geared towards; 1) development of a supportive web-based
program for older adults receiving OAAs and their caregivers that is theoretically driven and rooted in
behavioral change and technology use in older adults and 2) evaluating the web-based program for
acceptability, usability, feasibility, and user engagement. The long-term goal is to inform a larger RCT to test
the efficacy of the web-based program to improve OAA-specific outcomes of older adult patients.

Public health relevance
Oral anticancer agents (OAAs) account for over half of the new cancer treatments approved by the Food and Drug Administration. For older adults who are taking OAAs and self-managing care in the home environment, research is crucial for the development of supportive interventions to improve communication, information exchange, and self-efficacy in the management complex OAA and related symptoms/side effects. This study will explore concordance of the timing, frequency, and continuity of information sharing, communication, and knowledge gaps between patients, caregivers, and oncology health care providers specific to OAA treatment; examine patient-reported outcomes associated with OAA self-management; and to explore perceptions of supportive web-based program design features that may assist with the development of future intervention tool.